Center for the Assessment of the Public Health Impact of Tobacco Regulations

Project Summary Abstract
The Center for the Assessment of the Public Health Impact of Tobacco Regulations aims to provide evidence-
based and expert-informed modeling of the behavioral and public health impacts of tobacco regulations. The
Center’s primary scientific domains are Impact Analysis and Health Effects.
To evaluate the public health impacts of tobacco use and regulation, information must be gathered from
different sources on use behaviors, health risks and the impact of regulations on use patterns. This information
must then be synthetized and processed in a systematic and objective manner, helping policy makers to gauge
the impact that such regulations would have at the population level and aiding them in their decision-making
process. Simulation modeling of tobacco use patterns and related health outcomes can serve as a one of the
key tools to assist FDA in evaluating and predicting population-level benefits and harms resulting from
regulatory policies pertaining to new and existing tobacco products. When well applied, modeling also
becomes a way of organizing and synthesizing different sources of information and determining gaps in that
information, especially in situations where tobacco use patterns vary for different populations.
Our Center will have three projects based on detailed analysis of historical tobacco use patterns in the US and
using four established tobacco simulation models. The overarching aim of Project 1 (Impact Analysis, Health
Effects) is to conduct comparative modeling analyses of the impact of tobacco regulations and policies on
smoking and e-cigarettes use and related long-term health outcomes, including heart, pulmonary disease and
maternal and child health. Project 2 (Impact Analysis, Addiction) will extend two previously developed and well-
established models to examine the possible consequences of regulating nicotine in combusted tobacco
products, but the models will be general enough to consider other policies that affect the product content of
cigarettes, such as specific toxicants. Project 3 (Impact Analysis, Behavior) will model tobacco-related health
disparities associated with polytobacco use, and to investigate how potential policy options may impact
polytobacco use and downstream TRHDs. Four cores will serve the Center. An Administrative Core (AC) will
coordinate the work of the projects and cores; a Career Enhancement Core (CEC) will provide training to junior
investigators on the capabilities and limitations of tobacco simulation; a Data Analysis and Dissemination
(DAD) Core will analyze and provide the data for each of the models and develop infrastructure for
dissemination of model parameters and modeling results; Research Assessment and Input Development
(RAID) Core will generate parameter estimates for key policy and health effects modeling parameters via
systematic reviews and meta-analyses, and expert panels when sufficient data are not yet available.

Public health relevance
The Center for the Assessment of the Public Health Impact of Tobacco Regulations is to provide evidence- based and expert-informed modeling of the behavioral and public health impacts of FDA tobacco rules or other regulatory actions, focusing on Impact Analysis and Health Effects as Scientific Domains. Our Center will have three projects based on the detailed analyses of current and historical tobacco use patterns in the US using four established tobacco simulation models, with different approaches to provide a range of diverse insights.